Project 1: Molecular Predictors of Prostate Cancer Progression and Mortality

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PC) is a major cause of cancer-related morbidity and mortality. Prostate-specific antigen (PSA)
screening is controversial, and current consideration of high-risk men is inadequate. Additionally,
clinicopathological criteria are insufficient to differentiate indolent versus aggressive disease. The recent
discovery of a high prevalence of high-to-moderate penetrance germline cancer risk mutations in metastatic PC
(mPC) will lead to increased genetic testing and cascade testing of unaffected male relatives, thus identifying
men at high risk for developing aggressive PC. Preliminary evidence suggests the need for refined cancer
screening in this high-risk group. The overall intent of this project is to find men with germline mutations of
interest, both those with mPC as well as their male first-degree relatives who are at high risk for aggressive PC.
We seek to further characterize PC in the context of germline DNA repair gene (gDRG) defects using evaluation
of clinical, pathologic and molecular features, including targeted next generation sequencing methods; to recruit
at-risk male first-degree relatives through cascade genetic testing; and to offer a novel PC early detection clinical
trial incorporating novel biomarkers, including age-adjusted PSA thresholds, imaging, novel urine biomarkers
and the tumor prognostic biomarkers we discovered and validated in the past grant period, and to further
understand the crucial process of cascade genetic testing that will be required for optimal outcomes. The
proposed aims are:
Specific Aim 1: Determine clinical, pathologic and molecular predictors of gDRG mutation carriers
among men with mPC.
Specific Aim 2: Conduct an early detection study for male gDRG mutation carriers at high risk for mPC.
Specific Aim 3: Characterize the stepwise cascade genetic testing process from index cases to their at
risk first-degree relatives (FDRs).
This effort builds upon our current population-based SPORE work focused on finding and validating novel
prognostic biomarkers for aggressive PC (e.g., tumor DNA methylation and mRNA expression biomarkers for
distinguishing men at high risk for metastatic progression and PC-specific mortality) and transitions towards a
more direct clinical applicability. We believe our approach will be of high interest and relevance to men with
mPC and gDRG, and their sons and brothers who may be at increased risk for mPC due to carrying the same
gDRG mutation. At present, no unified PC early detection recommendations exist for men at increased PC risk
defined by inherited gDRG mutations. Our PC early detection clinical study will use established and novel
minimally invasive biomarkers with a goal of changing the standard of care for this high-risk group.

Public health relevance
PROJECT NARRATIVE Prostate cancer is a major cause of mortality and newly-identified germline mutations may identify men at high risk for aggressive tumors. The proposed study will ascertain and recruit germline cancer risk mutation carriers from: 1) population- and clinic-based incident cases of metastatic PC to find index cases with germline cancer risk mutations; 2) to conduct a PC early detection study incorporating novel biomarkers for unaffected, male germline mutation carriers (including first degree relatives of those with metastatic PC who are mutation carriers); and 3) to understand the cascade genetic testing process what will facilitate an innovative recruitment strategy for recruiting men at highest genetic risk of aggressive prostate cancer. Ultimately, the goal is to identify those men at highest-risk for aggressive PC and conduct a novel early detection trial, which will lead to evidence-based management strategies to improve prostate cancer outcomes.